252CFPDMS AND FABMS FOR HIGH-MASS MASS SPECTROMETRY

This proposal is to upgrade a thriving and productive institutional mass spectrometry (MS) facility with newer instrumentation to allow the analysis of much larger biological molecules than is presently possible, in order to more rapidly and ably contribute to the solution of important biological problems. The proposed instrumentation is a Californium 252 Plasma Desorption time-of-flight MS (252-CfPDMS) system and a high-mass magnetic deflection Fast Atom Bombardment MS (FABMS) system. The latter will be realized by retrofitting a 10,000 dalton (at 8 kV) magnet to a current standard Kratos MS50 system. These instruments will be shared by 7 major and numerous minor NIH-supported users. In project I the 252-CfPDMS and high-mass FABMS MS50 will be used for the structural analysis of a number of important biological molecules including modified and unmodified proteins, oligopeptides and oligosaccharides including: amphiphilic peptides (MW 1500-3000); human eosinophil major basic protein (MW 12,000); aequorins (MW 20,000); opiate-peptides (MW greater than 500); DNA predicted protein sequences (MW 500-20,000); and various glycoconjugates (MW 500-20,000). In project II the new high-mass capability will be used for the study of the structure of calmodulin-binding peptides, 13-C-tryptophan biosynthetically incorporated into proteins, and studies on the structure of lipid binding proteins. In project III the structure elucidation of human cholecystokinin neuropeptides (MW greater than 3000) will be tackled. In project IV (AM 25409) calcium binding proteins will be sequenced (MW 10,000-28,000). In project V the oligosaccharide structure of glycoprotein hormones will be determined (MW 1000-5000). In project VI lipooligosaccharide antigens from atypical mycobacteria (MW 1000-5000), and complex proteophosphogylcan antigens from M. leprae and M. tuberculosis (MW greater than 1000) will be examined. In project VII structural analysis of heparin fragments generated by heparinase will be carried out. A particularly important aspect of this work will be the direct comparison of 252-CfPDMS with high-mass FABMS for these typs of analyses, particularly with respect to the useful analytical mass range attainable, the sensitivity of analysis, and the amount of structural information (fragmentation) obtained.